Interdisciplinary Musculoskeletal Research Training Program

Abstract
The long-term, overall mission of this T32 is to provide a comprehensive and multi-level training program,
exposing trainees to transdisciplinary science, and providing the building blocks to launch a long-lasting career
that address pressing issues in musculoskeletal research. Within this five-year program, we will focus on the
concept of interdisciplinary musculoskeletal research. Specifically, the proposed training program will provide
integrated training for five predoctoral students in our three thematic areas: 1) MSK Development and Aging;
2) MSK Imaging and Translational Studies; and 3) MSK Cancers and Osteoimmunology. Our selected faculty
within these themes align with the central concept of interdisciplinary research and have a strong track-record of
mentoring predoctoral students. Our selected faculty within these themes align with the central concept of
interdisciplinary science and have a strong record of accomplishment of mentoring predoctoral students and
cross-disciplinary collaboration. Faculty within the MSK Development and Aging theme focus on understanding
how mechanisms governing correct formation of MSK tissues and how these processes go astray with age. Early
detection of MSK conditions aids in the management of MSK conditions, which is the focus of faculty within the
MSK Imaging and Translational Studies theme. Lastly, faculty within the MSK Cancer and Osteoimmunology
theme aim to identify potential treatments for MSK cancers and explore how MSK tissues, including cancers,
interface with the immune system. Along with these topical foci, our training program incorporates methods to
achieve specific training goals, including: 1) exposing trainees to broad MSK research topics and methods
that address MSK conditions; 2) supplying training on ethics and reproducibility within research; 3) delivering
skills needed to develop independent lines of research; and 4) providing networking and career development
opportunities. This training program will ensure that trainees from diverse backgrounds will be in the best
possible position to contribute effectively to advancing MSK science.

Public health relevance
Narrative Musculoskeletal diseases account for 1 in 9 trips to primary care physicians’ offices. There is a tremendous and increasing need for developing new and effective therapies for musculoskeletal disorders to reduce pain and improve the general health and quality of life of our patients. This training grant focuses on exposing young scientists to a broad range of musculoskeletal disorders and encouraging them to pursue a lifelong involvement in understanding the mechanisms of painful musculoskeletal conditions and developing new therapies for these maladies.